Mechanical integrity of memory systems in mild cognitive impairment

PROJECT SUMMARY/ABSTRACT
Normal physiological aging is associated with a gradual decline in cognitive function across the lifespan, which
is exacerbated by the prevalence of mild cognitive impairment (MCI) in the elderly and its progression to
Alzheimer’s disease (AD). The overall objective of this project is to identify neural substrates degenerated in
aging and MCI and that result in cognitive impairment, and to establish these substrates as targets for
rehabilitative strategies aimed are arresting or reversing cognitive decline. Viscoelastic properties of the human
brain measured in vivo with magnetic resonance elastography (MRE) have shown to be sensitive to the
structure, function, and health of tissue. In particular, MRE has shown that the brain softens in
neurodegenerative conditions and that viscoelastic properties of specific structures reflect associated cognitive
function in healthy adults; however, the links between viscoelasticity and cognition have yet to be established
in populations experiencing decline in cognitive function, such as in aging and MCI. This project seeks to
characterize the mechanical integrity of specific memory system structures (i.e. the hippocampus, prefrontal
cortex, and associated white matter tracts) through their viscoelastic properties in a geriatric population. We
will (1) determine how mechanical integrity of brain tissue is degraded in aging and MCI; (2) determine the
relationships between mechanical integrity and memory performance; and (3) determine how the mechanical
integrity and associated function is related to fitness level and can be recovered through exercise training. At
the end of the project, we will have established brain viscoelasticity as a neural substrate critical for memory
function and impairment in a geriatric population and as a target for rehabilitation aimed at improving cognitive
function and reducing the burden of disease.

Public health relevance
PROJECT NARRATIVE This project proposes to characterize the viscoelastic mechanical properties of the structures of the brain responsible for memory in a geriatric population using magnetic resonance elastography (MRE). Through this project, we will determine how these mechanical properties are impacted in aging and mild cognitive impairment, how they are related to impairment in memory function, and whether these properties and related cognition are impacted by fitness and exercise training. At the conclusion of this project we will have established neural tissue viscoelasticity as a substrate modifiable by rehabilitation strategies, and a target for recovering cognitive function.